Age-Related Clonal Hematopoiesis of Indeterminate Potential (CHIP) in Exercise Responsiveness

Despite advances in diagnostic and therapeutic paradigms, cardiovascular disease (CVD)
remains a primary cause of death across the world. Traditional risk factors for CVD are primarily
metabolic in origin, including obesity, sedentary lifestyle and insulin resistance. Cardiometabolic
diseases are associated with inflammation and chronic exercise training has been shown to
decrease inflammation. Clonal hematopoiesis of indeterminate potential (CHIP) is the age-
related expansion of somatic clones in hematopoietic stem cells secondary to mutations
associated with the development of hematologic malignancy and represents a state of
heightened inflammation. CHIP is associated with coronary artery disease (CAD) and incident
cardiovascular outcomes, however the relationship between CHIP and CRF has not been
evaluated. We have identified metabolic biomarkers that are associated with CRF and incident
cardiovascular events; as well as CHIP, suggesting a potential link between CHIP-induced
inflammation and impaired metabolic function leading to CVD. It is unknown whether CHIP is
associated with worse baseline CRF and whether it may predict response to chronic exercise
training, providing an opportunity to improve personalized care for CVD prevention. The overall
objectives of this application is to determine the role of CHIP, an emerging inflammatory aging
biomarker, in CRF and cardiometabolic responses to chronic exercise interventions and identify
metabolic dysregulation underlying this relationship. Our specific aims are (1) Determine if CHIP
is associated with worse baseline CRF and predicts heterogeneity in response to chronic
exercise training in patients with cardiometabolic disease and (2) Evaluate potential metabolic
mechanisms underlying CHIP, CRF and response to chronic exercise training. To achieve these
aims we will leverage two randomized clinical trials of patients with metabolic syndrome and
perform targeted sequencing of CHIP driver genes. For Aim 1, we will test associations of CHIP
with baseline peak oxygen uptake (pVO2) and change in pVO2. For Aim 2, we will use
inflammatory marker, plasma and skeletal muscle metabolite data to determine whether
metabolic dysregulation mediates the relationship between CHIP and CRF. The research
proposed here will allow me to build on the following skills: 1) analysis of somatic genetic
variant; 2) computational and statistical skills in multi-omic datasets; and 3) metabolomic
analyses including systems biology approaches to analyses. The data gathered during this
award period coupled with ongoing mentorship and a multi-disciplinary research environment
will prepare me to fulfill my long-term goal of becoming an independent physician-scientist.

Public health relevance
Using the research approaches in this project, we will determine the role of Clonal Hematopoiesis of Indeterminate Potential (CHIP) in cardiorespiratory fitness, including the role of CHIP as a predictor of heterogeneity in responsive to exercise training, which will expand our understanding of the impact of CHIP in cardiometabolic disease. In addition, we will clarify the role of metabolic dysregulation, testing mitochondrial and peroxisomal metabolites in individuals with CHIP and cardiometabolic disease to identify potential mechanistic and future therapeutic targets to improve the lives of people worldwide with cardiovascular disease.